Professional Development Core

Professional Development Core Project Summary / Abstract.
Professional development is a key ingredient for the Montana Clinical and Translational Research Center’s
(CTRC) overall goal of building clinical and translational (C&T) research capacity. For Montana C&T
researchers, there exists a critical gap in the training and mentorship required to initiate, support, and sustain
competitive C&T research and the community populations that they serve. We hypothesize that faculty and
practitioners with appropriate training and mentorship support will develop into successful and impactful C&T
researchers. The long-term goal of the Professional Development (PD) Core is to have a coordinated training
and mentoring resource that is dynamic and continuously informed by the needs of the C&T research
workforce. Our objective is to develop a user-informed training and mentorship platform to service the
professional development needs of emerging C&T researchers as well as the needs of the other CTRC Cores
that support those researchers. We will achieve this objective through three aims. Aim 1: We will conduct
needs assessments to identify training and professional development priorities to support C&T research. Aim
2: We will design, promote and deliver trainings, workshops, and other professional development activities for
the CTRD research workforce. Aim 3: We will host a formal mentorship program to support both CTRC funded
researchers and others in the emerging C&T research workforce.